INTRAVENOUS ENALAPRILAT FOR DIAGNOSIS OF SECONDARY HYPERTENSION

This study will measure plasma renin activity before and after administration of intravenous enalaprilat to determine whether this ACE inhibitor can be used as a fast, reliable, safe test to screen hypertensive patients for primary aldosteronism and renovascular hypertension.